ABSORPTION, TURNOVER, AND BIOCHEMICAL STUDIES OF ZINC IN MAN

The purpose of this study is to produce mild zinc deficiency in human subjects by dietary restrictions of zinc. It evaluates biochemical, immunological, and clinical effects as a model for the effects of zinc deficiency in natural populations.